INDUCTION OF CHROMOSOME CHANGES IN MAMMALIAN CELLS

There is a general concern that many environmental chemicals to which humans are exposed to are mutagenic. Several metal compounds have been identified through occupational exposure and laboratory testing as potential carcinogens. Therefore, screening of these agents is of paramount importance. In the proposed study, the ongoing investigations on the influence of heavy metal salts on the induction of chromosome aberrations, sister-chromatid exchange and micronuclei in CHO cells will be performed. Additionally, a detailed study will be conducted on the effect of various arsenic compounds on the above parameters. the student participants will be involved in all phases of the investigation. They will be introduced to the techniques of mammalian cell culture, cytogenetics, and genetic toxicology. Through involvement in MBRS research, the student participants will be motivated to pursue advanced degrees in health-related sciences.